The role of satellite cells in skeletal muscle hypertrophy with aging

Project Summary
The loss of skeletal muscle mass with age is of clinical importance because it is associated with increased
morbidity and mortality, as well as a marked deterioration in the quality of life. There is also a heightened
interest in the identification of cellular and molecular mechanisms responsible for the lack of an anabolic
response of aged muscle to hypertrophic stimuli. The use of satellite cells to treat loss of skeletal muscle mass
is considered a promising therapeutic strategy given their stem cell characteristics and essential role in post-
natal muscle growth and regeneration. The results of our studies have prompted us to perform mechanistic
analyses of both of the well-known function of satellite cells; fusion to myofibers to provide additional nuclei for
hypertrophic growth, to other functional consequences of satellite cell expansion that occurs in response to
various exogenous stimuli such as exercise, as the increase in satellite cell abundance in response to
mechanical overload far exceeds myonuclear accretion associated with increased myofiber size. We reported
satellite cells were necessary for optimal long-term hypertrophic growth of skeletal muscle by regulating the
extracellular matrix. Activated satellite cells repressed fibroblast collagen production via extracellular vesicle
(EV) delivery of miR-206, revealing a previously unrecognized function of satellite cells, in addition to providing
a mechanism through which satellite cells communicate with other cells within muscle. We now have in vivo
single-cell (sc)RNA-seq evidence from Pax7-tdT reporter mice of a satellite cell intercellular communication
network in which satellite cells communicate with FAPs/fibrogenic cells and endothelial cells during
hypertrophic growth. Aim 1 will test the hypothesis that aging negatively impacts this communication network
inhibiting proper remodeling of the extracellular matrix thereby inhibiting hypertrophy. We have also developed
a novel mouse model that allows us to simultaneously deplete satellite cells and label resident myonuclei, Aim
2 will use this model and single-myonuclear (smn)RNA-seq to characterize age-dependent changes in the
resident myonuclear transcriptome and identify mechanisms that enable short term hypertrophy in the absence
of satellite cells in adult mice, which is lost in old age. Aim 3 will use an additional newly developed reporter
mouse that enables specific and stable labeling of satellite cell nuclei to determine how aging alters the
satellite cell-derived myonuclear transcriptome in response to a hypertrophic stimulus. We hypothesize that in
aged muscle, satellite cell-derived myonuclei have altered transcriptional output that does not promote a
hypertrophic response, and that impaired fusion of satellite cells or defective satellite cells may negatively
impact resident myonuclear transcriptional activity contributing to impaired growth. Defining fusion-dependent
and -independent roles of satellite cells and age-associated changes that negatively impact muscle adaptability
will identify potential new targets to promote skeletal muscle growth in the face of inactivity, during aging and in
the face of muscle wasting diseases.

Public health relevance
Narrative A decrease in skeletal muscle mass is of clinical importance because it is associated with increased morbidity and mortality, as well as a marked deterioration in the quality of life. A broad patient population is affected by significant losses in muscle mass including those afflicted by various systemic diseases, chronic physical inactivity and sarcopenia. The purpose of this grant is to better understand the role of skeletal muscle stem cells (satellite cells) in the blunted growth response to exercise in the elderly, thereby providing a foundation for their therapeutic use to prevent or restore losses in skeletal muscle mass during aging.